High-throughput proteomics using submicroliter amounts of plasma for comprehensive assessment of the immune status

SUMMARY
Often, many different tests are performed to obtain a multiparameter assessment of the innate and
adaptive immune status. Such tests often include erythrocyte sedimentation rate, C-reactive protein
(CRP), procalcitonin, various complement pathway proteins, total antibody (Ab) isotypes and/or
subclasses, and specific Ab titers. All these tests are performed on different analytical platforms
requiring a separate aliquot for each test. Thus, even with modest sample consumption per test, there
is a substantial cumulative volume required for multiple independent tests. While these sample
requirements may not be prohibitive for healthy adolescents and adults, they are particularly
challenging in especially vulnerable populations such as premature newborns, and frail and/or elderly
individuals. For these populations, a wide range of different tests is often very important, however,
samples are often limited.
In agreement with the purpose of the funding opportunity “Development of Sample Sparing Assays for
Monitoring Immune Responses”, we propose to move four different protein assays onto a common
processing and analysis platform, which can be performed on the same submicroliter aliquot of plasma
thereby significantly reducing the sample volume requirements. The four protein assays of interest
include i) an expanded panel of complement components, ii) CRP, iii) antibody isotypes and subclasses
including a novel and innovative immunoglobulin domain-resolved map of the IgOme-related protein
repertoire (aka IgOme), and iv) the classical plasma proteome, i.e. ~400 well described proteins many
of which of clear immunological function. The quantitative information from all these assays will provide
us with an exquisite map of the immune status, a hypothesis that we will be tested by correlating our
findings with the anti-hepatitis B titer measured before and after hepatitis B vaccination in >500
newborns. Samples will be provided by Boston Children's Hospital's NIAID-funded HIPC (Human
Immunology Project Consortium), which will significantly increase the impact of this cohort beyond its
original scope. Taking the request of this funding opportunity for sample sparing to a different level, we
will advance our plasma proteomics pipeline to quadruple the throughput to at least 96 samples/day
and to quarter the plasma volume requirements to <100 nanoliter.
Thus, in the future, 1 microliter of plasma will be sufficient for tens of temporally independent LC/MS-
based protein assays, resulting in quantitative information for hundreds of proteins such that even a
miniscule amount of plasma from the smallest and/or most frail patients will be sufficient to establish
an exquisitely detailed and unbiased molecular map of immune status of any person.

Public health relevance
PROJECT NARRATIVE The proposed research will develop a single LC/MS-based platform that allows for discovery proteomics as well as the targeted analysis of immune system-relevant protein groups requiring less material and less time than previous methods. Such assay will enable us to establish molecular immune profile with hundreds of protein analytes even from the most vulnerable populations such as premature newborns or frail elderly adults, for whom samples availability is often extremely limited. These immune profiles of unprecedented resolution will enable faster response to challenges to the immune system such as infections and will inform a more rational approach to designing vaccines that work in all age groups.